Inhibition of an Apical cAMP/cGMP Transporter(MRP4)in the Gut InducesDiarrhea

PROJECT SUMMARY
The unifying hypothesis to be tested in this proposal is that the compartmentalized regulation mediated by
Guanylate Cyclase-C (GC-C), Cystic Fibrosis Transmembrane Conductance Regulator (CFTR) and Multiple
Drug-associated Protein-4 (MRP4) macromolecular complexes at or near the plasma membrane of gut
epithelial cells regulates cGMP mediated secretory diarrhea. We will test this hypothesis using transgenic
mice model (in vivo studies) and patient derived intestinal stem cells derived from crypts (enteroids) to study
fluid secretion in vitro. The proposed studies are highly significant because (i) it addresses the pathologies of
several deadly human diseases by utilizing models from humans and mice; (ii) it has clinical relevance and
implications; (iii) it is a multidisciplinary project covers basic biomedical studies, assay developments, and uses
personalized human stem cell cultures.

Public health relevance
PROJECT NARRATIVE In this grant proposal, we will address a novel mechanism of how protein-protein interactions can contribute to the progression of Travelers diarrhea (TD). We hypothesize that compartmentalized regulation mediated by Guanylate Cyclase-C (GC-C), Cystic Fibrosis Transmembrane Conductance Regulator (CFTR) and Multiple Drug-associated Protein-4 (MRP4) macromolecular complexes at or near the plasma membrane of gut epithelial cells regulates cGMP (cyclic guanosine monophosphate) mediated secretory diarrhea. By targeting this macromolecular complex, we may find ways to control fluid secretion and thereby control or cure the disease.